Prenatal Cadmium Exposure, Placental Transporter Proteins, and Child Health Outcomes

PROJECT SUMMARY
Cadmium, a non-essential metal, is persistent in the environment and highly detected in pregnant people.
Non-smokers are primarily exposed to cadmium via the intake of contaminated foods (e.g., cereals, breads,
vegetables). During pregnancy, cadmium concentrates in the placenta and can interfere with biological functions
and processes including hormone production and nutrient transfer. As a result, maternal exposure to cadmium
may contribute to preterm birth, reduced birth weight, and impaired child growth. Placental transporters such as
the breast cancer resistance protein (BCRP/ABCG2) may offer the fetus some protection by removing cadmium
from the placenta and returning it to maternal circulation. In vivo and in vitro models show that BCRP reduces
placental cadmium concentrations and cellular toxicity. In humans, a nonsynonymous BCRP polymorphism
(C421A/Q141K) that is present in 17% of people is associated with ~50% lower placental BCRP protein levels.
This F31 fellowship will first leverage existing data from an estimated 4,763 mother-child pairs across 13 cohorts
in the NIH’s Environmental Influences on Child Health Outcomes (ECHO) program to determine whether a
common variant in the BCRP gene may leave some fetuses more vulnerable to the adverse impacts of cadmium
exposure. Second, we will utilize novel placental proteomics data on transporters from a single ECHO cohort
(UPSIDE) to examine relationships between urinary and placental cadmium exposures and placental transport
protein concentrations. Our aims are: (1) To examine prenatal cadmium concentrations in relation to
gestational age at delivery and growth in the ECHO-wide cohort, considering effect modification by
BCRP genotype. We hypothesize that higher prenatal cadmium will be associated with increased risk of preterm
birth, earlier gestational age at delivery, smaller size at birth, and reduction-pattern growth trajectories. Further,
we hypothesize that these associations will be stronger in pregnancies with the reduced-function BCRP
polymorphism compared to the wild-type; (2) To examine placental BCRP protein concentrations in relation
to prenatal cadmium concentrations in the UPSIDE cohort. We will explore associations with timing of
birth and child growth. We hypothesize that placental BCRP protein concentrations will be inversely associated
with prenatal cadmium concentrations. In addition to BCRP, we will consider protein concentrations associated
with other less prominent gene variants and transporters involved in cadmium transport including a second BCRP
variant and the Multidrug Resistance 1 [MDR1] transporter. This work will provide insight on the role of placental
transporters in protecting against prenatal cadmium exposure and potentially identify a subpopulation of children
at heightened risk of cadmium toxicity due to the BCRP variant. In addition, this research can be extended to
improve our understanding of the developmental impacts of additional high priority contaminants that bind to
BCRP including bisphenol A, perfluorooctanoic acid (PFOA), and zearalenone.

Public health relevance
PROJECT NARRATIVE Evidence suggests that prenatal exposure to cadmium, a non-essential metal highly detected in pregnant people, may harm children’s health. Animal models demonstrate that the placenta, an organ that develops during pregnancy, may regulate fetal exposure to cadmium. This epidemiological study will translate these experimental findings to assess the placenta’s ability to regulate cadmium and protect against cadmium’s negative impacts on preterm birth and child growth, which may help to identify infants vulnerable to cadmium toxicity.